MOLECULAR BIOLOGY OF THE RETINA AND PIGMENT EPITHELIUM

The title of this project has been changed to more accurately reflect the thrust of the science. The retina and pigment epithelium are neuroepitheli tissues that work in close cooperation. Specific growth and differentiatin factors are found in the eye that guide development and interactions of individual ocular tissues to form a functional visual system. Studies on t s project are focused on an understanding of the molecular biology and molecular genetics of the retina and discovering new genes that are candidates for hereditary retinal degenerations. For example, ocular tissu synthesize a number of growth factors. There now appear to be several systems present that could self-regulate growth and metabolic activity in the retina-pigment epithelium complex and be involved in eye diseases. In this regard, we have cloned and characterized a unique protein secreted from fetal human pigment epithelial cells, called pigment-epithelial derive factor (PEDF), that is "neurotrophic" to cultured human retinoblastoma cell and may affect neural retinal development in vivo. This protein also is a potent "neuronotrophic" agent in that it promotes neuronal cell survival of cultured cerebellar granule cells. Finally, PEDF is "gliastatic" in that i markedly retards glial cell growth. Along with being a candidate gene in retinal degenerations, the uses of PEDF in neuronal transplant in retina an other CNS areas are obvious.